Optimizing and Projecting Lifestyle Behavioral Interventions to Sustain Long-term Health Behaviors and Outcomes in Focus Populations

Ninety percent of the $4.5 trillion in annual healthcare expenditures in the United States can be attributed to
chronic conditions.1,2 Many of these often co-occurring conditions, including obesity, diabetes, hypertension
and heart disease, can be prevented or improved by lifestyle change interventions (LCIs) such as diet and
exercise.3-8 However, African Americans (AA)9-26 and rural residents regardless of race,27-34 who have higher
risks of developing multiple chronic conditions (multimorbidity),35,36 often do not participate in LCIs due to
barriers specific to them. They therefore do not realize the benefit of reducing multimorbidity at lower costs,
with significant cost implications for payers and LCI implementers. To address these barriers and respond to
the SIP25-004 Project 1 requirements, we will pursue three aims that will collectively inform
policymakers and implementers on the LCI type and dose that maximize desired policy goals at the
payers’ available budget level. We will focus on LCIs targeting AA or rural residents or consisting of a
sufficient number of such participants. In Aim 1, we will conduct updated meta-analyses on the dose-response
relationships between these LCIs and long-term (6 months+) behavior changes (physical activity, diet),
improvement in cardiometabolic indicators (body mass index, blood pressure, serum sugar levels), and
prevention of multimorbidity (obesity, diabetes, hypertension, heart disease). This aim will help us understand
the effective LCI doses that may facilitate LCI adoption in these populations specifically. In Aim 2, we will
estimate LCI implementation costs and key factors associated with these costs, either by collecting cost
information directly from the published results (if available), or through direct measurement by estimating the
unit costs and quantities of labor and material inputs. This aim can help identify opportunities to lower
implementation costs. Finally, in Aim 3 we will combine the outcome information (from Aim 1) and the cost
information (from Aim 2) to conduct a new cost-effectiveness analysis of LCIs in achieving several desired
policy goals. Specifically, we will use the validated Future Elderly Model37 to project multimorbidity onset over a
lifetime in a nationally representative sample of AA and rural residents and estimate the cost effectiveness of
each LCI in reducing multimorbidity, increasing quality-adjusted life years, decreasing healthcare expenditures,
and increasing productivity gains from improved health. Finally, to ensure continued relevance of our research,
we will provide an online impact analysis dashboard for policymakers and LCI implementers to visualize cost-
effectiveness at various implementation costs and LCI types and doses. Throughout, we will engage
community stakeholders to help translate and disseminate our findings beyond academic audiences to
encourage adoption of cost-effective LCIs. Our research will inform the optimum allocation of resources to
alleviate the burden of multimorbidity and reduce cost for private, state, and federal payers as well as LCI
implementers that serve AA and rural residents.

Public health relevance
Chronic diseases, including obesity, diabetes, hypertension, and heart disease, contribute to 90% of the $4.5 trillion in annual healthcare expenditures in the United States. Many of these often co-occurring chronic conditions can be prevented or improved by lifestyle change interventions (LCIs), but African Americans and rural residents (regardless of race) often do not participate in LCIs due to barriers specific to them and therefore fail to benefit from reducing multiple chronic conditions at lower costs. To increase LCI adoption in these groups and improve the financial sustainability of LCI implementers serving them, we aim (1) to identify the optimal LCI dose by conducting updated meta-analyses on the dose-response relationships between LCIs and long-term health behaviors/outcomes; (2) to identify opportunities to lower costs by analyzing LCI implementation costs by LCI feature/dose; and (3) to balance optimal dose and lower costs by assessing the cost-effectiveness of LCIs in improving health and economic outcomes over a lifetime horizon, which can help LCI implementers identify the LCI type and dose that maximize outcomes at the available budget level.